Methamphetamine and HIV interactions in the regulation of glial activation

DESCRIPTION (provided by applicant): HIV-1 exposure is associated with methamphetamine (Meth) abuse. These two factors synergize in aggravating neuroAIDS symptoms and disease progression. One of the important consequences of Meth on innate immune cells is to change the balance of reactive oxygen species (ROS) and induce inflammatory markers, such as CCR5 and RANTES. These changes are believed to be dopamine-dependent, but we have observed that both ROS and CCR5 can be induced in dopamine-free systems. Interestingly, ROS in the CNS can signal the increase of NFkB levels and phosphorylation, and directly induce activation of promoters of inflammatory molecules. On the other hand, HIV Tat, which also induces ROS, has been shown to potentiate glial activation and neuronal damage induced by Meth and other drugs of abuse. HIV Tat, but not Meth, increases several TATA-box binding components in macrophages in vitro, suggesting that it can have a modulatory effect on promoters of inflammatory molecules that bear a TATA-box promoter domain in the promoter. We hypothesize that transcriptional signaling triggered by Meth-induced ROS interact with a TATA-box-dependent modulatory mechanism in the presence of HIV Tat. We propose to explore the role of ROS-induced pathways in the upregulation of CCR5 and RANTES on astrocytes and microglia by Meth and Tat, aiming to identify the players in a dopamine-independent mechanism. We will also investigate whether the induction of TATA-box binding elements is at the basis of the ability of HIV Tat to modulate ROS and inflammatory markers in the CNS, affect immune cell infiltration and interfere with drug-related stereotypic behaviors. Using an original approach we expect to unveil a basic mechanism of interaction between HIV and Meth in the aggravation of CNS pathology, which will open a new line of investigation with a translational reach.

Public health relevance
PUBLIC HEALTH RELEVANCE: Currently, we don't understand all of the cellular mechanisms whereby Meth upregulates inflammatory molecules such as CCR5 and RANTES and the mechanisms by which the interaction between Meth use and HIV exposure enhance brain viral load and pathology. We have evidence of a role for Meth-induced ROS in regulating CCR5 expression in a dopamine-independent fashion, and we have identified an ability of HIV Tat to upregulate TATA-box binding elements, which are regulatory components that can interfere with the expression of 10% of genes with expression high variability, such as chemokines, chemokine receptors, and several early response inflammatory genes. We will investigate whether ROS-induced transcription factors in the presence of Meth are modulated by a TATA-box based mechanism triggered by HIV Tat, altering the phenotype of glial cells towards a higher expression of CCR5 and RANTES, exacerbating the inflammatory milieu and promoting viral replication: these are potentially novel modes of regulation of molecules such as CCR5 in the context of drugs of abuse and HIV, relevant for immune function in the brain, and open an original translational perspective for understanding the susceptibility to inflammatory neuropathology in amphetamine users.